Genetically Dissecting Cholinergic Signaling in Body Weight Control

Abstract / Project Summary
Obesity-associated diseases such as diabetes and cardiovascular disease together account for the leading
cause of death in the United States. Roughly one-third of the U.S. population is obese, and it is estimated that
nearly half of the population will be obese within the next two decades. To date, studies investigating the
neural contribution to body weight control have focused largely on neuropeptidergic signaling in the
hypothalamus, a key brain region involved in feeding behavior. However, signaling from extra-hypothalamic
brain regions has also been implicated in regulating nutrient metabolism, appetite, and satiety. We have
recently uncovered a novel mechanism by which cholinergic signaling in the basal forebrain strongly influences
feeding and body weight control. This discovery provides intriguing evidence that cholinergic circuits in the
brain critically regulate feeding behavior and body weight homeostasis. To elucidate the mechanisms by which
forebrain cholinergic signaling influences body weight management, feeding behaviors, and metabolism, we
will test the hypothesis that downstream basolateral amygdalar (BLA) neurons and their projections to the
nucleus of accumbens (NAc) and ventromedial hypothalamus (VMH) mediate forebrain cholinergic action on
body weight regulation. Using a combination conditional genetic targeting, optogenetic manipulations,
electrophysiology, and behavioral analysis, we will set out to determine the role for direct downstream BLA
neurons that project to the NAc or VMH in mediating obesity induced by loss of forebrain cholinergic action.
The results from the proposed series of experiments using animal models with precisely targeted
manipulations of neuron activity will elucidate roles of specific cholinergic basal forebrain to BLA circuits that
differentially regulate the NAc and VMH in feeding and body weight control, providing needed insight into the
central mechanisms underlying appetite and body weight regulation.

Public health relevance
Narrative We have recently uncovered a novel role for cholinergic and glutamatergic projection neurons within the basal forebrain in body weight control. This project focuses on elucidating the underlying neurocircuits involving downstream basolateral amygdalar pathways that mediate basal forebrain cholinergic action on feeding and body weight control. Knowledge gained from these studies will provide needed insight into how cholinergic circuits in the central nervous system modulate metabolic and appetitive programs to regulate body weight.